PreventT2 Together: Examing the efficacy of couple-based lifestyle intervention to prevent type 2 diabetes

PROJECT SUMMARY/ABSTRACT
Nearly half of U.S. adults have or are at risk of developing type 2 diabetes. Lifestyle intervention is efficacious
and the first line of prevention among adults at high risk for type 2 diabetes. Unfortunately, outcomes in real-
world settings do not approach the initial efficacy trial findings, in part due to low rates of retention in the
intervention. Real-world programs have particularly struggled to retain participants who identify as members of
racial/ethnic groups that are disproportionately affected by type 2 diabetes, potentially exacerbating health
disparities. Given the strong influence romantic partners have on one another and the shared environment in
which couples typically live, lifestyle interventions that systematically include romantic partners have the
potential to address the research-practice gap. The purpose of this project is to examine the efficacy of
PreventT2 Together, a couple-based lifestyle intervention our team developed. The specific aims of the
research are: (1) to determine the efficacy of PreventT2 Together in a single-center, randomized clinical trial,
(2) to examine baseline relationship satisfaction as a moderator and perceived partner support as a
mechanism of lifestyle change, and (3) to quantify intervention retention and describe reach across recruitment
methods. We will recruit 162 couples (i.e., adults at high risk for type 2 diabetes and their romantic partners)
from community and healthcare settings, oversampling members of racial/ethnic minority groups. We will
randomize participating couples to individual (PreventT2; delivered only to partners at high risk) or couple-
based (PreventT2 Together; delivered to couples) lifestyle intervention conditions. HbA1c and objectively
measured moderate to vigorous physical activity (MVPA) will be collected from all participants at baseline (Pre)
and at the end of the 1-year intervention (Post). Participants will also report on lifestyle factors, health
outcomes, and relationship functioning at each of 13 time points (Pre, monthly during the intervention, and
Post). We focus on the patient-centered minimum clinically important difference (MCID) in outcomes, including
objectively-measured MVPA (primary outcome), as well as other aspects of lifestyle (nutrition, sleep), health
outcomes (HbA1c, weight loss, stress), and relationship functioning (perceived partner support) (secondary
outcomes). Situating lifestyle intervention within the romantic relationship context in which lifestyle change
occurs is likely to increase reach and improve retention and lifestyle change outcomes in real-world settings.
Our community-engaged approach to the development of the intervention and design of the proposed project
will ensure broad applicability and dissemination of results across communities, including racial/ethnic minority
groups that have not been effectively reached and retained. CDC review and approval of PreventT2 Together
for use as an alternate curriculum in the National Diabetes Prevention Program (National DPP) delivered
across the U.S. underscores the scalability of the intervention. If efficacious, PreventT2 Together has the
potential to impact individuals and their romantic partners’ quality of life and ultimately improve real-world
outcomes of lifestyle intervention to prevent type 2 diabetes.

Public health relevance
PROJECT NARRATIVE Nearly half of adults in the United States have or are at risk of developing type 2 diabetes. The overall goal of this community-engaged research is to examine the efficacy of an innovative couple-based lifestyle intervention to prevent type 2 diabetes that is applicable to a broad range of partnered adults in the United States. By simultaneously targeting lifestyle and perceived support from romantic partners, there is a high likelihood of creating lasting changes in both.